Artificial intelligence-integrated mechanistic modeling for rational design of nanoparticles to improve organ targeting and safety

PROJECT SUMMARY.
Inorganic nanoparticles (NPs) hold great promise as targeted drug delivery systems but tailoring
their pharmacokinetics (PK) to specifically target regions of interest remains a challenge. This
limits the clinical translation of NPs due to poor delivery efficiency and safety concerns associated
with off-target accumulation of NP-based formulations. Due to the interactions of NPs with
biological components, driven by their structural properties, customizing the PK of NPs requires
a quantitative understanding of the effect of NP structural properties on their whole-body
biodistribution, which in turn also governs their safety profile. Therefore, to enable rational design
of inorganic NPs to achieve organ targeting and safety, we propose to leverage artificial
intelligence to develop a toxicology-integrated physiologically-based pharmacokinetic model
(PBPK-Tox) capable of accurately predicting the whole-body exposure and safety of novel
nanomaterials, based solely on their structural properties, dose, and route of administration. For
this, we will (1) develop a PBPK-Tox model based on diverse datasets from literature, (2) establish
the quantitative relationship between NP properties, exposure, and toxicity, and (3) experimentally
test the model predictions of rational design for organ-specific targeting. Our proposed modeling
framework will enable efficient preclinical development of inorganic NPs (and accelerate their
clinical translation) by providing rational design guidelines through in-depth computational
investigation of biological and physicochemical variability on biodistribution and safety of NPs.

Public health relevance
NARRATIVE. As demonstrated by the utilization of nanoparticles for vaccine delivery during the COVID-19 pandemic, nanomedicine has the potential to transform human health. However, nanomedicine is yet to reach its full potential in several diseases, partly due to our inability to tailor nanoparticle delivery to organs of interest and the potential toxicity associated with nanoparticle accumulation in off-target locations. To overcome these challenges, we propose to use artificial intelligence, mathematical modeling, and animal experiments to generate guidelines for rational design of inorganic nanoparticles for improved clinical outcomes.